Determining factors of inflammation that support the expansion and function of long-lived effector cell CD8 T cells in a mature memory compartment

PROJECT SUMMARY/ABSTRACT
The use of specific pathogen free (SPF) mice has been instrumental in the advancement of immunological
research, reducing variability between experiments and institutions. However, it is becoming increasingly
evident that pathogen experience alters the immune system dramatically. This limits the translation potential of
discoveries in SPF mice, as humans are regularly exposed to pathogens from birth. Work from the Hamilton
lab and others has found that increasing the microbial exposure of mice through pet shop mouse cohousing
(COH) alters the immune compartment of mice to more accurately reflect that of an adult human. This change
is particularly evident in the memory CD8 T cell compartment. The CD8 T cell memory pool contains cells with
a wide range of trafficking patterns, effector functions, and longevity. In SPF mice, the CD8 T cell compartment
is dominated by naïve cells and central memory T cells. However, COH mice and adult humans contain
predominantly effector memory T cells, including long-lived effector cells (LLEC), a population described by the
Hamilton Lab. This proposal aims to understand how pathogen exposure and inflammation lead to the
expansion and maintenance of LLEC, and how the expansion of this cell population alters the overall function
of the T cell compartment. Aim 1 will determine what proinflammatory cytokines support LLEC formation and
persistence. Experiments will identify cytokines and other factors that lead to the increase in LLEC during
COH, via the use of RNA sequencing and CRISPR mediated genetic knockouts. We will also determine if we
can expand LLEC in the absence of pathogen exposure via administration of cytokines. Aim 2 will determine
how COH alters the function of LLEC, and address the consequences of skewing the memory compartment to
LLEC for responses to systemic and local infections. This aim will utilize adoptive cell transfers and an
inducible fluorescent reporter to determine if COH LLEC can protect against systemic and local infections.
Focusing on CD8 T cell memory, and incorporating RNA sequencing analysis, will support goals 1 and 2 of my
training plan, and the proposal will develop my skills as an academic scientist as a whole (training aim 3). The
Center for Immunology at the University of Minnesota is an ideal environment to complete this proposal as
there is a strong record of impactful immunological research and postdoctoral training, particularly within T cell
biology. Altogether, these studies will yield critical information regarding the importance of pathogen exposure
and inflammation on the memory T cell compartment, as well as novel information on the functionality of
subsets of memory CD8 T cells. These data will be useful to develop vaccines and T cell therapies with
increased translation potential.

Public health relevance
PROJECT NARRATIVE: PUBLIC HEALTH RELEVANCE Traditional SPF mouse models do not accurately reflect the immune compartment makeup observed in humans, particularly the T cell compartment. This proposal utilizes pet store mouse cohousing to normalize mouse pathogen exposure with the goal to explore the maintenance and function of long-lived effector CD8 T cells. These studies will help better understand the factors that promote T cell maintenance and function in a model with normal levels of pathogen exposure.